WHCOHH Community Engagement Core

1. Summary/Abstract
The overall goal of the Woods Hole Center for Oceans and Human Health Community Engagement Core
(WHCOHH CEC) is to prevent human heath exposure to harmful algal bloom (HAB) toxins by: (1)
strengthening collaboration and information sharing among regional stakeholder communities concerned with
HAB impacts; (2) expanding classroom education and participation in Oceans and Human Health (OHH)
science; and (3) actively engaging healthcare and public health communities to improve awareness and
diagnosis of OHH-related illnesses. Proposed CEC activities build on programs, capabilities, and infrastructure
developed under the current WHCOHH grant, but include new directions and audiences to increase reach and
impact. The CEC will continue to foster communication and data sharing with stakeholders in New England
and will initiate new efforts to promote training and technology transfer. Proposed activities will further the
development and adoption of the WHOI HABhub data portal, an open source webserver that aggregates
diverse HAB data in near real time. New functionality will enable user participation in sensor image
classification, providing all users with deeper engagement and education related to HAB identification and
importance while soliciting meaningful contributions to ongoing research. Our educational outreach will develop
innovative materials and programs to serve as model curricula for teaching OHH concepts and content, with an
emphasis on empowering underserved communities of students. Finally, our efforts to develop effective
involvement of public health and healthcare providers and professionals in OHH address an area of
engagement that has been identified as a priority need for improving the accurate and timely diagnosis and
reporting of illnesses caused by OHH threats. Our efforts are local, regional, and national in scope, and involve
partners with substantial expertise and depth of experience in OHH and community engagement, as well as
the active participation of WHCOHH investigators to promote transparent communications and multi-directional
exchange of information. The CEC plan for evaluation is robust and includes joining with the Administrative
Core to establish a CEC Advisory Committee (CEC-AC) to regularly evaluate CEC progress and success.
Metrics to evaluate the effectiveness of CEC activities will be defined in collaboration with partners and
WHCOHH investigators, and are included in a program logic model for the CEC to evaluate efficacy over time.